Bone Marrow Histopathological Changes in Neoplastic and Non-Neoplastic Diseases

In FY22, in collaboration with Dr. Kazandjian and Dr. Landgren, we evaluated the effects of carfilzomib, lenalidomide, and dexamethasone (KRd) with lenalidomide maintenance therapy as early intervention in high-risk smoldering myeloma. High-risk smoldering myeloma has a 5-year risk of progression to symptomatic multiple myeloma of approximately 75%. Treatment with lenalidomide decreases the risk of progression; however, novel triplet regimens are superior, and earlier disease may be more treatment sensitive.
In this single-arm, single-center, phase 2 nonrandomized controlled trial, responses were evaluated at every cycle during KRd treatment and every 3 cycles subsequently. Bone marrow biopsies and imaging were performed by cycle 8 and then annually. The study enrolled patients from May 29, 2012, to July 23, 2020, seen at the NIH Clinical Center. Patient key eligibility criteria included a diagnosis of high-risk smoldering myeloma based on the Mayo Clinic, Spanish, and/or Rajkumar, Mateos, and Landgren criteria. Patients received eight 4-week cycles of intravenous carfilzomib 36 mg/m2 (first 2 doses, 20 mg/m2), dexamethasone (20 mg, cycles 1-4; 10 mg, cycles 5-8 twice weekly), and lenalidomide 25 mg (days 1-21) followed by twenty-four 28-day cycles of maintenance lenalidomide 10 mg (days 1-21). The primary outcome was to determine the rates of minimal residual disease (MRD)-negative complete response (CR). Key secondary outcomes included duration of MRD-negative CR and progression to multiple myeloma.
A total of 54 patients (median age, 59 years, range, 40-79 years) were enrolled, with a median follow-up time of 31.9 months (range, 6.7-102.9 months). Serial bone marrow MRD monitoring and PET/CT imaging were performed at CR or at cycle 8 completion, whichever occurred first, and after cycles 20 and 32. After maintenance therapy, patients were observed with routine and myeloma laboratory examinations every 3 months and annually with PET/CT and bone marrow biopsy with MRD assessment indefinitely. Bone marrow MRD involvement was assessed by histopathological, immunohistochemical and flow cytometric evaluation of clonal plasma cell burden. The MRD-negative CR rate was 70.4% (95% CI, 56.4%-82.0%), with a median sustained duration of 5.5 years (95% CI, 3.7 years to not estimable). Importantly, MRD negativity was achieved irrespective of age, sex, race/ethnicity, cytogenetic risk, or high-risk criteria. The 8-year probability of being free from progression to multiple myeloma was 91.2% (95% CI, 67.4%-97.9%), and no deaths occurred. Nonhematologic grade 3 adverse events occurred in 21 patients (38.9%) and included thromboembolism, rash, and lung infection. There were no grade 4 events.
Results of this phase 2 nonrandomized controlled trial suggest that treatment of high-risk smoldering myeloma with novel triplet regimens, such as KRd and lenalidomide maintenance therapy, may alter the natural history of smoldering myeloma by significantly delaying development of end-organ disease.